TRANSPORT-DEPENDENT ACTIONS OF ADENOSINE ANALOGUES

Pharmacologic modulation of the physiologic and biochemical processes regulating MNB growth and differentiation will be systematically investigated in tissue culture and in situ tumor models. Emphasis will be placed upon the synthesis and pharmacologic evaluation of analogues directed against the naturally occurring and biologically important substrate, adenosine. The study will consist of four major components: 1. Evaluation of structure activity relationships between adenosine analogues and pharmacologic response. 2. Elucidation of the mechanism(s) and enzymatic sites of action of adenosine analogues. 3. The role of active membrane localized nucleoside transport systems and intracellular phosphorylation reactions as determinants of drug action. 4. The therapeutic application of adenosine analogues as selective inhibitors of MNB tumor cell growth in mixed cell populations containing bone marrow cells. Chemotherapeutic applications of transport-dependent cytotoxicity will be evaluated by determining their efficacy in purging neuroblastoma tumor cells from bone marrow cells.